CORE-- DATA MANAGEMENT

The purpose of the Data Management Core is to insure the validity of the instruments being used to measure cognition and insure the appropriateness of the study designs and the validity of the methods used to perform them. The Core will: 1) assess the operating characteristics of instruments, 2) provide statistical input to the experimental design, 3) determine sample size and power for trials, 4) oversee the collection of data on the clinical trials, 5) edit and verify the protocols, 6) enter and verify the data into computer storage, 7) return the protocol to the investigators as appropriate, 8) choose and perform the statistical analyses, 9) write the statistical section of reports and publications.